Project 2: Informing oral nicotine pouch regulations to promote public health

PROJECT SUMMARY – PROJECT 2
Historically, the tobacco industry manipulated nicotine concentration and form to offer a range of smokeless
tobacco (ST) products to appeal to both new and established users. Termed by the industry as the “graduation”
program, they provided new users with “starter products” with low nicotine concentration and low freebase
nicotine and “mature” users with higher concentrations of nicotine, mainly in the freebase form, to maintain
dependence. They are now following the same playbook for oral nicotine pouches (ONPs), manipulating the
nicotine dimensions of concentration and form, and more recently have begun manipulating isomer
composition through the use of synthetic nicotine. While ONPs may have promise as a less harmful alternative
for smokers and ST users who completely switch, the potential risk for ONP uptake among young new users is
concerning. The overall theme of The Ohio State University Tobacco Center for Regulatory Science is: “Flipping
the Script”: Using the Industry’s Nicotine Playbook to Maximize Public Health. Just as the tobacco industry
manipulates nicotine to create ONPs that appeal to young people, with the evidence produced by Project 2 (P2),
we posit that the FDA can regulate the nicotine dimensions in ONPs, making them unappealing to new users
while still providing smokers and ST users a less harmful but appealing and satisfying alternative. P2 will inform
regulations that position ONPs as a public health benefit rather than a threat by identifying the characteristics of
nicotine that best support switching to ONPs and evaluating corresponding changes to the oral microbiome
among adult smokers and ST users. In Phase 1, using a double-blind, cross-over design, exclusive smokers
(n=80) and ST users (n=80) will be randomized to high or low nicotine concentration, and then engage in 5
single-product laboratory use sessions of their usual brand and 4 ONPs (random order) that range in freebase
fraction (low, high) and isomer (racemic, >99% S-nicotine). Outcomes include plasma nicotine pharmacokinetics,
subjective effects, and behavioral economic demand indices. In Phase 2, the same participants, after a 1-week
usual brand control period, will substitute a randomly assigned ONP for their usual brand for 4 weeks. Study
outcomes include use behaviors, including complete switching, measured via ecological momentary assessment
and biochemically confirmed (anatabine and anabasine), count of unused ONPs, subjective effects, behavioral
economic demand indices, and oral microbiome assessment. P2 is significant and innovative because it uses a
mix of tightly controlled in-lab procedures and ad libitum, naturalistic use of commercial tobacco products to
assess how nicotine concentration, form, and isomer affect the addiction potential and health effects of ONPs.
This is the first study of the combined nicotine dimensions with the intent of facilitating switching from cigarettes
and SLT to ONPs without increasing youth uptake. P2 addresses the FDA areas of Addiction, Product
Composition & Design, Toxicity, Behavior, and Health Effects, and will inform ONP nicotine regulations designed
to foster complete switching for established smokers and ST users.

Public health relevance
The tobacco industry has historically manipulated nicotine in its products to increase their appeal and potential for addiction for the widest possible audience, including young people and non-users. They are now doing this with newer products, like e-cigarettes and oral nicotine pouches. Our center will study how these manipulations affect young people and adults, with the goal of helping the FDA develop regulations that will make these products less appealing to young people, including non-users, but not older adult smokers and smokeless tobacco users who may benefit from their use.